OBESITY, CONDITIONING, AGE, AND SERTRALINE EFFECTS ON METABOLISM

This study examines the relationship of body composition and physical fitness to insulin sensitivity, adipose tissue metabolism and sympathetic nervous system activity, and the effect of weight loss and Sertraline, a serotonin re-uptake blocker on these relationships.